PATHFINDER: Finding the genomic and clinical pathways underlying heterogeneity in complex disease

Complex diseases are heterogeneous in their etiology and clinical manifestation. This heterogeneity hampers
understanding of their causes, and requires new precision medicine strategies to apply targeted interventions
in homogeneous disease subgroups. While statistical genetics methods have provided key insights into
disease etiology in recent years, they are not optimized to expose the mechanisms underlying the
heterogeneity observed among patients. Therefore, novel strategies to identify and understand disease
heterogeneity are needed. In this K99/R00 proposal, we introduce PATHFINDER: a comprehensive research
program to reveal the mechanisms leading to heterogeneity in complex diseases. This research program
will be prototyped for schizophrenia, inflammatory bowel disease and coronary artery disease, selected for
their high heritability, availability of powerful GWASs, and the rich functional genomic and clinical individual-
level data available. These diseases provide, thus, excellent templates for extending this approach to a range
of complex diseases. To achieve the program objectives, the following analytical strategy is proposed:
- In Aim 1 (K99 phase), the context in which putative causal genes act will be determined. This involves
identification of tissues and cell types with the highest gene expression and specificity, and identification of
other genes functionally related to the genes of interest (e.g. based on metrics such as gene co-expression).
- In Aim 2 (K99 phase), our recently developed PRSet software and tool will be utilized to compute pathway-
based polygenic risk scores (PRSs), identifying, for each individual, the biological pathways with the highest
genetic risk to disease. This will enable the identification of shared and distinct genetic profiles across patients.
- In Aim 3 (R00 phase), Dr. García-González will apply the techniques and knowledge gained from Aims 1 and
2 to develop a precision medicine framework for stratifying patients from large biobanks. In Aim 3.1, PRSs
associated with clinical factors and disease symptoms will be identified. In Aim 3.2, statistical and machine
learning methods will be used to stratify patients into more genetically and clinically homogeneous subgroups.
This research program is expected to have a significant translational impact by identifying more homogeneous
disease subgroups that will inform mechanistic hypotheses, ultimately leading to more etiology-specific
interventions and treatments. Furthermore, the training during the K99 phase will be crucial for Dr. García-
González’s scientific development and to set the foundations of her independent research program.
The combination of: (i) Dr. García-González’s background in experimental research and statistical genetics, (ii)
the expertise of the mentoring team in PRSs methods development, functional genomics and experimental
validation approaches, and (iii) the world-leading research performed on medical genetics and genomics at the
Icahn School of Medicine at Mount Sinai in New York City, provides an ideal lever for Dr. García-González to
climb the academic career ladder and to become an independent investigator.

Public health relevance
NARRATIVE The research in this proposal aims to uncover the mechanisms underlying heterogeneity in complex diseases through the identification of: (i) the context (tissues, cell types, gene networks) in which causal genes operate, and (ii) shared and distinct genetic risk profiles among patients. This knowledge will be integrated with additional clinical data in statistical and machine learning models to stratify patients into more homogeneous disease subtypes, contributing to the development of new precision medicine strategies. The study will be initially applied to schizophrenia, inflammatory bowel disease, and coronary artery disease, acting as a guide in the psychiatric, cardiometabolic, and immunological fields.